Ultrasensitive multiomic platform using epitope-targeted DNA methylation mapping

Candidate Eligibility Statement
The goal of this diversity supplement application is to provide career development support for Dr. Allison
Hickman, a bioinformatician who aspires to (and with support could perform) leadership roles in commercial
science. Women have been under-represented in science leadership, particularly in the field of bioinformatics,
and this award would formally address the issue by supporting a truly talented individual. Dr. Hickman is a US
citizen and full-time employee at EpiCypher Inc., a Small Business Concern (SBC) eligible to submit applications
to the National Institutes of Health. EpiCypher was recently awarded an SBIR Phase II Grant from NHGRI [R44
HG011875] that is currently in year one (of two) and is eligible for diversity supplement support.
4/20/2023
Dr. Allison Hickman - Diversity Supplement Candidate (Research Scientist) Date
4.20.2023
Dr. Martis Cowles - EpiCypher Signing Official (Chief Business Officer) Date

Public health relevance
This section is not applicable per the funding opportunity announcement. ASSIST required a document to be uploaded to pass system validations.